Animal Metabolic Physiology Core

Animal Metabolic Physiology Core: Project Summary/Abstract
The Animal Metabolic Physiological Core (AMPC) is a new Vanderbilt Diabetes Research Center (VDRC)
Core. In prior VDRC cycles, mouse services for VDRC investigators had been provided by the Vanderbilt
Mouse Metabolic Phenotyping Center (MMPC; U24 DK059637). The Vanderbilt MMPC, an original and
continuous participant in the national MMPC national program, has been on the forefront of development,
standardization, and dissemination of techniques to study metabolism in mice for 20 years. NIDDK will retire
the national MMPC Program in June 2021. At the time this was announced, the VDRC was engaged in
strategic planning for its competitive renewal. VDRC investigators expressed concern as to how funded grants
could be executed and new scientific projects developed without these mouse services. Thus, the VDRC
proposes to create the AMPC to make these mouse services available to VDRC investigators. The rationale for
the AMPC is based on overwhelming feedback from VDRC investigators expressing a need to continue the
sophisticated mouse services that had been so impactful in their research (54 VDRC users, >24,000 services,
98 publications used this type of service in past 5 years). The AMPC will provide state-of-the-art research
techniques and expert guidance in integrative metabolic physiology to VDRC investigators. The AMPC
services and expensive equipment that will be made available through the AMPC are impractical to develop or
acquire and maintain in the lab of an individual investigator. Plus, the AMPC’s expertise and services
overcome barriers to studying the mouse and are highly integrated with VDRC services provided by the
Analytical Services Core, the Genomics and Human Physiology Core, and the Islet and Pancreas Analysis
Core. The AMPC will have an important role in training of fellows, students and staff which will serve to
propagate valuable concepts and technology. Thus, the AMPC and its services are vital to address the
research aims of funded grants and for the development of new scientific projects for VDRC investigators.